Choreography of Eukaryotic DNA Replication

PROJECT SUMMARY
Faithful replication of the genome is a core mission of all dividing cells. Accordingly, cells have evolved
mechanisms to monitor replication fidelity and to coordinate completion of replication with other cell cycle
events. In eukaryotes, chromosome replication is initiated at multiple initiation sites (origins), which are a
key target of the cell’s regulatory mechanisms ensuring proper genome maintenance. Cells can regulate
origin choice (which potential origins they use), efficiency (how likely they are to use it in any given cell
cycle), and initiation time, to choreograph the overall duplication of the genome. Disruption of this
choreography has been linked to a variety of human disorders including cancer. Although origins are not
conserved at the sequence level, the protein machinery is highly conserved, allowing discovery of key
aspects of these fundamental processes in simple models such as Baker’s yeast because of its small
chromosomes, well defined origin sequences, ease of altering chromosome structure, and exceptional
systems for genetic and genomic analysis. A recent discovery is the key role played by the rDNA—the
locus containing tandemly-repeated copies of ribosomal RNA genes—in modulating genome duplication
and maintenance. Over the next five years, this project will investigate how the choreography of
chromosome replication is established and why it is so important in eukaryotes: How is rDNA replication
regulated, and how does rDNA copy number affect genome stability? How are origin preference and
replication timing determined genome-wide? And how do alterations in the choreography of genome
replication contribute to phenotypes such as those seen in human disorders?

Public health relevance
Brewer The proteins and regulatory networks that choreograph genome replication are conserved across eukaryotes; through our study of genome replication in the yeast Saccharomyces cerevisiae, we have discovered that the timing of replication of the rDNA (the repeated locus that codes for the RNA component of ribosomes) is essential for coordinating genome replication with the exit from mitosis. We propose to continue our exploration of the temporal and spatial regulation of replication in yeast by focusing on the rDNA and on the proteins that define and regulate replication origins. This work will expand our basic understanding of the mechanisms regulating chromosome duplication and illuminate questions of importance to human health. Project Narrative